Resource Center for Alzheimer's and Dementia Research in Asian and Pacific Americans

ABSTRACT
Asian and Pacific Americans (APAs) have undergone the greatest growth among all racial/ethnic groups in the
U.S. between 2000 and 2020. In the New York City/New Jersey (NYC/NJ) area, older (65+) Asian Indian and
Chinese American populations have increased by 73% and 74% over the past ten years. While claims-based
studies in the U.S. have previously suggested lower prevalence of Alzheimer’s disease (AD) and related
dementias (ADRD) in older APAs, this finding may have resulted from underdiagnosis associated with not
having culturally and linguistically appropriate tools, clinicians, or systems. Older APAs with AD/ADRD
in the U.S. thus face both the problem of under-diagnosis and under-provision of care as a whole, even as
great disparities exist within and between APA subgroups. What’s more, the COVID-19 pandemic and the
associated anti-Asian discrimination brought greater social isolation to older Chinese and non-Chinese APA
adults over the past three years than other groups. These factors together formed the foundation of the
Resource Center for Alzheimer’s and Dementia Research in Asian and Pacific Americans (RCASIA) with
missions of 1) increasing scientists underrepresented in AD/ADRD-related Behavioral, Social, and Economic
Research biomedical research through innovative models of mentoring and community interaction; 2)
advancing the rigor and impact of AD/ADRD pilot studies in older APAs through Common Data Elements and
data-sharing; 3) serving as a national resource for linguistically/culturally tested and validated tools to assess
cognition, function, and AD/ADRD care in APA populations. Focusing on the theme of People, Culture,
Place, Time, RCASIA will leverage strong institutional support and relationships to solicit pilot applications
from Early Stage Investigators (ESIs). We will actively engage and encourage applications from ESIs at
NYC/NJ-based Minority Serving Institutions through pre-application RCASIA internships and partnership
commitments from large funded studies prospectively recruiting disaggregated older APAs. Scientist
mentoring will occur in the Research Education Component (co-led by a returning REC Core Lead and a newly
recruited yet established AD/ADRD Education/Psychosocial Core Lead) involving mentoring/method-based
Pods and ethnicity-based Teams. REC will be supported by the Leadership & Administrative Core, the
Measurement & Analytical Core, and Community Liaison & Recruitment Core in selecting each year’s class of
RCASIA Scientists, enhancing multi-generational method and career development in Pods, conducting
transdisciplinary engagement with Community & Lived Advisors in Teams, and evaluating the outcomes of
Scientists, effectiveness of the Pod/Team model, impact of Common Data Elements and data sharing, and
long-term relationships between RCASIA and funded Scientists. Returning and new faculty’s commitment to
diversity, equity, inclusion, and access and APA brain health will contribute to RCASIA’s goal of becoming the
epicenter for AD/ADRD-related Behavioral, Social, and Economic Research in older APA populations.

Public health relevance
NARRATIVE Aging Asian and Pacific Americans (APAs) face risks for Alzheimer’s disease and related dementias (AD/ADRD), stress from immigration and acculturation, as well as pandemic-related social isolation. The Resource Center for Alzheimer’s and Dementia Research in Asian and Pacific Americans (RCASIA) will identify, mentor, and elevate underrepresented scientists to conduct AD/ADRD-related behavioral, social, and economic research in disaggregated APA populations to improve their brain health, care, and well-being.